Funding for Renal/Urothelial Early Career Researchers at the American Physiology Society Summit ETG Sessions

Abstract
This application requests funding to support the travel expenses of early career researchers focusing
on renal and urothelial physiology, and presenting their research at the Epithelial Transport Group
(ETG) scientific sessions at the American Physiological Society (APS) Summit Meeting 2023. This
meeting is newly formed and replacing the previous Experimental Biology meeting where APS was
one of the core societies. The new APS Summit meeting will be the stand alone, annual meeting of
the APS. All ETG sessions will occur in this annual meeting. APS Summit will take place April 20-23rd,
2023 in Long Beach, CA. The meeting will be held at the Long Beach Convention Center, which
offers an ADA-compliant infrastructure for individuals with disabilities and special needs. ETG has a
longstanding history of promoting interactions among physiologists from diverse backgrounds
who study biological processes in epithelia and encourages students, postdoctoral fellows, and
instructors to develop research careers in epithelial biology. Based on prior experience and survey
data, trainees consistently view the annual ETG sessions as a valuable training experience that
reinforces their interest in the field and promotes retention in epithelial-centric biomedical research.
Thus, we strive to optimize trainee exposure to ETG-related events by providing travel award support
for promising early career investigators with limited travelresources. This application will solely
focus on supporting early career researchers focused on KUH-centric related research
areas.
This year, ETG will work in collaboration with the Renal Section in development of renal and urothelial-
focused topics and sessions. All trainees who submit ETG-based abstracts to the Renal Section will
be eligible for travel awards. The abstracts will be reviewed and scored jointly by members of
both the Renal Section and ETG Steering Committees. The travel awards will be allocated based on
merit. Award amounts will be contingent on the funds that are available. Regardless of the amount,
however, the budget incorporates an additional supplement to awardees with child/family care needs
in order to encourage meeting participation by trainees with primary child/family care
responsibilities. This is extended to other non-traditional family support needs. Top scoring
abstracts will be selected for oral presentations in the Hebert Lecture, and other Renal/ETG-based
session. In 2023, these prestigiouslectureships will recognize Drs. Sylvie Breton (Hebert) and Mark
Donowitz (Ussing) for their important contributions to epithelial biology and transport. This format
has proven popular among trainees, as it provides an exciting opportunity for talented early career
physiologists to present their research alongside preeminent scientists in a formal, but collegial
setting. We will continue our one-day “pre-meeting” symposium. This will provide additional
opportunities for junior investigators to orally present their work in a less formal atmosphere, with
networking coffee breaks, lunchesand networking sessions. A revised, interactive area framed as
“The Hub”, will serve as a meeting point for ETG-related Renal research, and provide an area for
flash-talks, discussions and networking amongst prominent scientists. This will include the “Meet the
Experts” sessions. Given ETG’s commitment to diversity and trainee mentoring, we believe that the
support provided by this application will dovetail with the proposed meeting structure to enhance
career development of early career researchers interested in epithelial physiology. Together, this
will serve our long-term goal of maintaining the pipeline of epithelial biologists in biomedical
research careers related to the goals of KUH.

Public health relevance
Narrative The purpose of this application is to request travel funds to support trainees who wish to attend and present their research at the American Physiological Society Summit Meeting (on April 20-23rd, 2023 in Long Beach, CA) and be part of a unique educational forum for scientists who study renal and urothelial cell function in health and disease. By supporting the travel, education, and development of these promising early career scientists, we hope to expand and diversify the current epithelial biology workforce, ultimately increasing research in the scope of the KUH.